MULTIGRID METHODS FOR CONVECTION DIFFUSION REACTION EQUATIONS

For complex, non-linear convection-diffusion-reaction processes such as those encountered in whole organ analysis, it is vitally important to solve a system of nonlinear partial differential equations as fast as possible. In this section we proposed the development and application of the very efficient techniques known as multigrid methods for solving systems of equations. In consultation with various leaders in this field, we have determined that this project does not merit further effort and has been cancelled. The project leader, Richard P. Beyer, Jr. has left the Resource.